Research in Environmental Health Sciences

This is a revised competing renewal application to the National Institute of Environmental Health[unreadable] Sciences for years 44 through 48 of the P30 Environmental Health Sciences (EHS) Center grant to the NYU[unreadable] School of Medicine, Department of Environmental Medicine. The primary mission of this broad-based[unreadable] Center is to focus a diversity of talent on the recognition, evaluation, prevention and control of the adverse[unreadable] impact of environmental factors on human health. This is achieved through the interactive programs of the[unreadable] research cores that provide intellectually stimulating foci for studies addressing the Center's goals, and is_[unreadable] supported by centralized facilities that provide individual researchers with information, expertise and[unreadable] technical assistance in specific operations (e.g., analytical chemistry, histopathology, animal care and[unreadable] specialized animal exposure, gene expression and genotyping analyses, proteomics, computational biology,[unreadable] biostatistics), and state-of-the-art equipment (e.g., DNA sequencers, atomic force microscopy, microarray and[unreadable] protein chip technology). This Center also has a strong focus on ambient air pollution effects, environmental[unreadable] exposures to heavy metals, the role of dietary factors in the causation and prevention of environmentally-induced[unreadable] human cancer, and hormonal, radiation, and occupational exposures in human carcinogenesis and[unreadable] disease. The Center reaches out to the community (local and regional) providing information and education[unreadable] on environmental issues to K-12 students, teachers and community groups, in addition to, training graduate[unreadable] and medical students for productive careers in environmental health research. The Center also guides its[unreadable] members into new research areas involving modern technology or into research areas that are timely and will[unreadable] have significant environmental impact (e.g., The World Trade Center disaster). The Center supports both[unreadable] investigator-initiated pilot projects, as well as encourages initiatives in new areas that the Center deems[unreadable] important for the future of our environmental health. The Center's coordination and application of broadbased[unreadable] scientific talents and research techniques will: 1) facilitate research that relates environmental factors[unreadable] to human disease; 2) identify mechanisms responsible for the adverse health effects produced by[unreadable] environmental agents; 3) develop methods for the detection, prevention and control of environmental[unreadable] exposures that cause or exacerbate human diseases; and 4) study the relationship between genes and[unreadable] environmental factors that activate or deactivate genes that contribute to differences in population and interindividual[unreadable] susceptibilities to the development and progression of human diseases..[unreadable]